Care Team and Practice Level Implementation Strategies to Optimize Pediatric Collaborative Care: A Cluster-Randomized Trial

PROJECT SUMMARY/ABSTRACT
Chronic care models (CCM) that deliver evidence-based practices (EBP) by multidisciplinary provider teams
with primary care physicians (PCP) and behavioral health (BH) providers (as care managers, CM) have
improved BH outcomes in adults1-3 and children/teens, but their widespread application is impeded by
implementation barriers at multiple levels. As an example, our clinical trials document the benefits of a
simplified cross-diagnosis CCM protocol for child behavior problems and ADHD (Doctor Office Collaborative
Care; DOCC; MH064372), but DOCC requires targeted implementation support to enhance uptake and
address practical barriers at the care team (e.g., low coordination) and practice/leadership levels (e.g., low
priority). Further, meta-analyses suggest that science provides few answers for how to overcome such
obstacles as trials have not tested implementation strategies to scale-up a pediatric CCM. As a theory-based
implementation intervention, Facilitation delivered by an outside expert with providers/teams (external) or
practice manager/leaders (internal) has enhanced provider competency to deliver an EBP and leadership or
organizational-level commitment to EBP implementation. External facilitation strategies applied to a care team
(TEAM) may engage validated targets (i.e., team functioning), whereas internal facilitation strategies applied to
leaders (LEAD) may engage practice-level targets (i.e., implementation support) to enhance uptake. They may
interact to enhance EBP uptake and patient outcomes. This R01 application proposes a randomized, hybrid
type 3 effectiveness-implementation trial to: 1) test the main and interactive effects of TEAM and LEAD
facilitation augmentation on provider implementation and clinical outcomes, 2) test for target engagement and
mediation at the team and leadership levels, and 3) examine selected practice, provider, and family
moderators of implementation. The state-wide sample includes 24 primary care practices from the medical
home program of the American Academy of Pediatrics-Pennsylvania Chapter. After standard training in the
DOCC EBP, all practices will be randomized to one of four conditions: 1) No TEAM or LEAD; 2) TEAM only; 3)
LEAD only, and 4) TEAM+LEAD. TEAM and LEAD facilitation will be delivered via videoconference on a
graded schedule over 18 months. Care teams will deliver DOCC to 25 children who meet the clinical cutoff
(75th percentile) on the Pediatric Symptom Checklist-17 Externalizing scale and their caregivers. We will collect
practice/provider measures from 175 practice staff (0, 6, 12, 18, 24 months) and 600 caregivers (i.e., 0, 3, 6,
12 months) to support all analyses. Collection of generalizable data to routine pediatric practice will yield new
knowledge about the impact, mediators, and moderators of CCM implementation. In one of the first large-scale
pediatric trials of a service system intervention to address these aims and respond to RFA-MH-18-701 and the
NIMH’s Strategic Plan (4.2), this trial will advance the implementation science knowledge needed to refine
promising strategies for accelerating the delivery and scale-up of DOCC in a pediatric medical home.

Public health relevance
PROJECT NARRATIVE Chronic care models (CCM) that deliver evidence-based practices (EBP) by multidisciplinary teams can improve children’s early behavioral health, but efforts to transport them to pediatric practice – such as our simplified cross-diagnosis CCM protocol for child behavior problems and ADHD (Doctor Office Collaborative Care; DOCC; MH064372) – often face scientific, technical, and practical challenges. Given promising findings by our team showing that such obstacles can be overcome to enhance EBP implementation by applying external and internal facilitation augmentation strategies applied to care teams (TEAM) and leaders (LEAD), respectively, we propose to conduct a hybrid Type 3 effectiveness-implementation trial to test the main and interactive effects of these TEAM and LEAD implementation conditions on provider uptake and clinical outcomes, and to test for their target engagement/mediation and moderation. By proposing one of the first large pragmatic pediatric trials of a CCM-based EBP to address these aims in response to RFA-MH-18-701 and the NIMH’s Strategic Plan (4.2), this research will advance the implementation science knowledge needed to optimize promising strategies for promoting the delivery and scale-up of DOCC in a pediatric medical home.